Human endogenous provirus inhibition of HIV replication

Abstract
This application seeks continued support for a new project, based on discoveries made during a research
program, funded by the NCI for over 45 years, on biology and evolution of retroviruses and their roles in AIDS
and cancer, with a particular focus on Human endogenous retroviruses (HERVs). The studies described in this
proposal will ccenter on a provirus in the relatively recent HERV-K (HML-2) group that integrated in a site on
chromosome 3, band q12.3 of a common human/gorilla ancestor at least 8 million years ago. In prior work, we
discovered that this provirus has several unique features consistent with its having evolved into a restriction
factor capable of strongly blocking the virion assembly step in replication both of the reconstructed, infectious,
HERV-Kcon and, remarkably, also of HIV. Adaptations to this role include an LTR mutation that leads to
widespread expression in all normal human solid tissues and a mutation (or mutations) in the gag CA encoding
region that lead to transdominant misassembly of the Gag precursor of the infecting virus at the cell membrane.
The current proposal will follow up on these observations with the aims of obtaining a detailed understanding
of the mechanism of co assembly and inhibition of HIV Gag assembly and release, understanding the evolution
of the 3q12.3 provirus and the scope of its activity against other retroviruses, isolation of HIV escape mutants
resistant to 3q12.3 inhibition, and testing the feasibility of using reactivation of the 3q12.3 provirus in HIV target
cells as a novel method of prevention of HIV replication.

Public health relevance
Narra$ve In prior studies of human endogenous retroviruses (HERVs), we encountered one that has evolved into a restric=on factor whose expression blocks replica=on of both the same HERV and some other retroviruses including HIV. The goal of the project proposed here is to obtain a detailed understanding of the mechanism of restric=on of both viruses by this provirus; to elucidate its evolu=onary history; and to test whether it can be ac=vated in target cells to protect the host against the consequences of HIV infec=on.